NCTN Supplement Request for Additional Restricted Capitation

SWOG NCTN OPERATIONS SUPPLEMENT REQUEST GY09
SWOG is requesting additional funding for restricted capitation.

Public health relevance
SWOG NCTN OPERATIONS SUPPLEMENT REQUEST GY09 SWOG is requesting additional funding for restricted capitation.